Limited Competition: Continued Follow-up of Subjects and Initiation of a Second Case-control Cohort in The Environmental Determinants of Diabetes in The Young Study (TEDDY)

Project Summary/Abstract
The funded parent application intent is to provide resources to the TEDDY Data Coordinating
Center (DCC) to continue studies focused on the identification of environmental exposures that
lead to the initiation of autoimmunity and its progression to type 1 diabetes. This request for
funds for an administrative supplement will continue the DCC’s efforts towards the support of
TEDDY subject follow-up and the second case-control cohort analysis (NCC2). This additional
support enables uninterrupted laboratory support, sample storage, and investigator small group
meetings for discussion and scientific planning.

Public health relevance
Project Narrative The goal of The Environmental Determinants of Diabetes in the Young Study (TEDDY) is the identification of infectious agents, dietary factors, or other environmental agents, including psychosocial factors which trigger type 1 diabetes (T1D) in genetically susceptible individuals. Identification of such factors will lead to a better understanding of disease pathogenesis and result in new strategies to prevent, delay or reverse T1D.